Neurocognitive Aging & Analytics Research Education (NAARE)

PROJECT SUMMARY/ABSTRACT
To prepare ourselves for the aging of our increasingly diverse population, we must increase minority
representation in the sciences, and train young researchers to understand neurocognitive aging and
Alzheimer's disease and related dementias (ADRD), and associated health disparities. CSUF and USC
propose an innovative and transformative program entitled, “Neurocognitive Aging & Analytics Research
Education (NAARE)” that builds upon our current biomedical research education program on data science and
brain health. In the coming decades, the United States and the world will face a rapidly growing aging
population, with an insufficient number of experts trained in ADRD research to accommodate this increase.
Even though ethnic and racial minorities, including African Americans, Latinos and Native Americans/Alaskans
comprise over a third of the U.S. population, they are under-represented in aging studies, leaving us with
insufficient knowledge of the genetic and environmental risk factors that contribute to cognitive decline in these
populations. The representation of minorities in science and biomedical fields also remains comparatively low.
Increasing the number of trained researchers from these underrepresented groups may provide insights into
social contextual issues and other factors related to underrepresentation, which may subsequently promote
access to these important populations in order to subsequently improve health disparities related to
neurocognitive aging in these vulnerable populations. Therefore increasing the number of underrepresented
aging researchers continues to be a high national priority. The NAARE program addresses this gap as follows:
Aim 1: Provide NAARE scholars hands-on research experiences: Engage three consecutive cohorts (n =
10 per year) of predominantly underrepresented minority undergraduates (50% female) in a 1.5 - year faculty
mentored, student-driven research focusing on neurocognitive aging, ADRD, and related health disparities
and modifiable risk factors. Aim 2: Develop educational curricula: Traditional and multimedia curricula will
be developed for NAARE scholars and also targeted towards a larger diverse student audience (n = 4,500) on
the following: basic science behind normal brain aging and ADRD; health disparities, modifiable risk factors
and neurocognitive aging; neuroimaging and analytics; and research methods in neurocognitive aging. Aim 3:
NAARE Scholar Graduate/Career Preparation: To ensure sustainability and student success, NAARE
students will engage in ongoing faculty advising, receive exhaustive graduate school application support via
hands-on guidance, and explore first-hand, research intensive universities. In-depth mentored, yet student-
owned research experiences that integrate intensive neurocognitive aging and ADRD training, and belonging
in the broader scientific community will result in successful future scientists. This program will lead to a greater
number of students from underrepresented backgrounds choosing careers in neurocognitive aging and
succeeding at them. Our students will become diverse role models for future students for generations to come.

Public health relevance
PROJECT NARRATIVE Brain-related aging and health, including Alzheimer's disease and related dementia (ADRD) have a profound impact on individual physical and mental functioning, and also on families and society. Therefore, investigation of neurocognitive aging and ADRD is crucial to our society and the individuals within it; however, we have too few trained underrepresented scientists to address the challenges of neurocognitive aging and ADRD faced by our increasingly diverse aging population. Our project will develop an exhaustive research training experience in neurocognitive aging ranging from basic neurobiology of neurodegenerative conditions, modifiable risk factors and health disparities related to neurocognitive aging, which will subsequently establish a talented, committed, and sustained pipeline of underrepresented students reflective of community demographics, who have unique perspectives, capable of addressing critical neurocognitive aging challenges in our changing world.